SCH: Smart User-Effective Data-Enabled (SUEDE) Shoe for Ankle Injury Prevention

The proposed research is relevant to public health and well aligned with the mission of NIAMS because it
addresses the substantial need to improve effectiveness in prevention of ankle sprains, one of the most
common musculoskeletal injuries that can significantly impact physical activity and quality of life. While
external passive supports, such as ankle taping and bracing, are the most widely used approaches to
prevent ankle sprains, their long-term use makes patients overly reliant on the passive and constant
support, which leads to ankle muscle and soft tissue atrophy. Furthermore, this approach not only restricts
inversion-eversion motion but also dorsiflexion-plantarflexion motion, which in turn may alter natural
lower-extremity biomechanics. This project seeks to study a unique smart shoe system, using integrated
scientific solutions of engineering, computing and behavioral science, to overcome these limitations and
provide enhanced support for individuals at risk of ankle injury. Our specific aims are: (1) to design and
implement a smart shoe system that integrates robust, real-time estimation of biomechanical data and
activity recognition from wearable sensors with soft actuators capable of actively adjusting the stiffness of
the ankle brace; (2) to quantify and model ankle stiffness and foot loading trajectory in healthy individuals
as well as in people at risk of ankle sprains; (3) to integrate an injury prediction algorithm and a
closed-loop feedback controller that provides active ankle support to prevent sprains; and (4) to refine the
developed algorithms for free-living use and design an intuitive mobile user interface that provides
summative injury risk metrics in real-time. We will validate and evaluate the proposed smart shoe system
by closely engaging with clinical partners to ensure the system is tailored toward optimal clinical
integration in mind. The smart shoe system is clinically significant because it will allow clinicians to better
understand foot-ankle mechanics and their correlation to ankle injury risk during various physical activities
and help them provide effective and summative feedback to the users in a timely manner to promote their
adherence to ankle injury prevention strategies. Successful development of the system and rigorous
assessment of its patient- and clinic-centered perceived utility will lay the groundwork for follow-up clinical
trials specifically aimed at investigating the long-term effect of interventions on preserving/promoting ankle
health and enhancing behavioral adherence to clinical recommendations.

Public health relevance
This research addresses the substantial need to improve effectiveness in prevention of ankle sprains by introducing a smart shoe system that actively supports the ankle as needed without hindering natural ankle motion and provides an intuitive user interface with injury risk metrics to promote user adherence to clinical prescriptions. This solution is expected to substantially enhance the effectiveness of the current practice of passive ankle bracing or taping and contribute to the long-term goal of promoting ankle health.